Northwestern University Skin Biology and Diseases Resource-based Center

Abstract: Northwestern University (NU) is renowned for its interdisciplinary cutaneous biology research program, which focuses on epidermal structure and function. The NU Skin Biology and Disease Resource Center (SBDRC) adopts the theme "Keratinocyte and its Microenvironment" to promote exceptional basic and translational research. With 41 Senior Bench members, 8 Junior Bench members, 1 new non-member P&F Awardee, and 13 Collaborating Clinical Associate members, the SBDRC spans 13 University departments and 5 divisions within the Department of Medicine. The ultimate goal of the SBDRC is to provide the infrastructure for discovery that can translate into improved patient care. The SBDRC consists of four cores: Administrative (Admin), Skin Tissue Engineering and Morphology (STEM), Translating Experimental Skin Testing with Immune Tracing, Informatics and Technology (TEST IT2 ), and Gene Editing, Transduction, and Nanotechnology (GET iN). The Admin Core fosters collaboration through its Enrichment Program, Pilot and Feasibility (P&F) Grants. The STEM Core offers diverse primary healthy and diseased human skin cells and tissue, but also simple and complex multi-cell 3D human skin equivalent models using cells from healthy or diseased skin. Cells for models can be modified genetically, including with inducible gene manipulation, and viewed using innovative tools, such as live imaging. The Core also offers a range of morphogenetic processing services. Our next generation TEST IT2 Core provides state- of-the-art single-cell and spatial genomic tools with a focus on interactions between keratinocytes and other cell types, such as immune cells, fibroblasts, melanocytes, and nerve afferents. The Core offers immunological assays and the unique opportunity for controlled human testing. Skin-specific bioinformatics pipelines and resources for investigator-initiated projects are available. The GET iN Core generates a broad range of viral constructs and provides nonviral delivery techniques using nanotechnology, such as spherical nucleic acids and high-density lipoprotein (HDL)-like nanoparticles, as well as electroporation. The Core offers CRISPR/Cas9 gene knockout, a genome-wide CRISPR screen, and epigenomic approaches (CRISPRa and CRISPRi). The STEM, TEST IT2 , and GET iN Cores collaborate internally and with other University Cores to provide education, technical services, and interpretation of results. The NU SBDRC is well-positioned to offer users the opportunity to translate their basic findings into animal and human cell models, as well as the clinical setting, empowering skin biologists at NU and beyond to significantly advance our understanding and treatment of skin disease.

Public health relevance
Public Health Relevance: The SBDRC enhances research in cutaneous biology at Northwestern University and throughout the U.S. by providing networking and learning opportunities, advanced technology for performing studies, and shared data, thereby attracting new investigators into skin research. The Administrative Core, with its Enrichment, Pilot Grant, and the Research Cores will foster cooperative interactions among scientists and between scientists and clinicians, which will translate into innovative research, discovery, and ultimately better health care for patients with skin diseases.